Administrative Supplement: iLas Ring TIRF for 3D super-resolved imaging of cellular force magnitude and direction

This document is not a requirement for this submission.

Public health relevance
This document is not a requirement for this submission.